Quantifying the spatial stability of sensory stimulation projected fields for sensory neuroprostheses

PROJECT SUMMARY
This research is motivated by the goal of improving the lives of individuals with sensorimotor deficits
through somatosensory feedback. Recent neuroprostheses development has demonstrated providing sensory
feedback improves the control of neuroprosthetic devices. The technological and clinical development is
approaching long-term investigations for ultimate translation to independent home use of a neuroprosthesis. As
such, a growing number of studies suggest that the projected fields (PFs), the locations of perceived sensations
through stimulation, are relatively consistent over the study period. However, there has been little focus on
determining the spatial stability of the PFs. Spatial stability is important because knowing where percepts occur
will be critical for designing somatosensory neuroprostheses that can be used in daily life without the need for
regular recalibration of the stimulation. My goal is to develop a quantitative approach to determine the spatial
stability of sensory stimulation PFs. By establishing an understanding of how PFs are spatially preserved over
time, I envisage the quantitative framework to bridge the intuition of PF stability and the experimental data
collected from sensory stimulation experiments. I will leverage PF data obtained from two different electrical
stimulation techniques and determine the co-occurrence between PFs, their spatial contiguity, and investigate
functionally relevant PFs.
Aim 1 will determine the co-occurrence and spatial contiguity of PFs. I will develop new algorithms
that take into consideration the overall activation frequency of each PF, its co-occurrence with other PFs, and
the spatial contiguity. To determine the statistical significance, I will use a statistical null model that sets a
benchmark of “by-chance” level stability. The statistical null model will be determined through binomial process
simulations. Aim 2 will determine the spatial stability of functionally relevant PFs. Functional relevance is
important because a critical goal for somatosensory neuroprostheses is to provide reliable somatosensory
feedback and enable independent home use for daily tasks. In this aim, I will determine regions of the hand that
are important for different prosthesis grips used in functional tasks. I will then compute the co-occurrence of
these functionally relevant regions and determine their spatial stability.
Fundamentally, Aim 1 focuses on PF spatial stability from empirical data regardless of sensory stimulation
techniques, while Aim 2 focuses on PF spatial stability for functional relevant regions. When completed, this work
will be applicable to all somatosensory neuroprostheses development in which ensuring PF spatial stability is
crucial to establish long-term somatosensory feedback for independent home use.

Public health relevance
PROJECT NARRATIVE This research will develop a quantitative framework to determine the spatial stability of sensory percept locations elicited from stimulation to individuals with somatosensory loss. This quantitative framework will compute spatial co-occurrence and contiguity, as well as investigate functionally relevant regions. The techniques created in this work can be generalized to different sensory stimulation techniques and applied to future sensory neuroprosthesis design for independent use.